Determining the interplay of MAIT cells and the translocated microbiome in HIV-induced neuroinflammation

Summary/Abstract
Significant progress in the treatment of HIV with suppressive ART has led to long term viral suppression;
however, people living with HIV (PLWH) continue to experience CNS perturbations including HIV-associated
neurocognitive disorders (HAND). Persistent CNS immune activation is a hallmark of HIV neuropathogenesis,
and persists even in PLWH who are on suppressive ART. The identification of persistent intestinal dysbiosis in
people living with HIV (PLWH) and ongoing neurological disorders despite ART has highlighted the importance
of gut–brain communication in the pathogenesis of central nervous system (CNS) co-morbidities in PLWH.
However, the question regarding the identity of immunological, microbial, and central nervous system
components responsible for this crosstalk remains unclear. Our studies of mucosal-associated invariant T cells
(MAIT cells), which are innate-like T cells able to recognize conserved bacterial ligands presented by MHC-
related 1 (MR1) molecule, during HIV-1 infection have shown that MAIT cells are activated early during infection
and expand in blood and colonic mucosa coincident with peak viremia, in a manner associated with emerging
microbial translocation. Moreover, preliminary single cell transcriptomic and TCR sequencing data from our
group has detected a large proportion of MAIT cells in cerebrospinal fluid (CSF) of PLWH, suggesting MAIT cells
may serve as immune mediator of the gut-brain axis. Yet, a MAIT cell immune mediated gut-brain axis
mechanism has not been studied in HIV infection. We hypothesize that MAIT cells are a major immune cell type
that mediate the crosstalk between gut dysbiosis, microbial translocation, immune cell dysfunction, and CNS co-
morbidities in PLWH. To comprehensively study MAIT cells across compartments including the CNS, we will
leverage already collected biospecimens of gut, cryopreserved peripheral blood mononuclear cells, plasma, CSF
fluid, cryopreserved CSF cell pellets, and postmortem brain tissues samples from a previous non-human primate
study conducted by MHRP using SHIV-1157ipd3N4. In Aim 1, we will longitudinally compare and contrast the
relationship between the gut microbiome to the MAIT cells residing in CSF, blood, gut, and brain during SHIV
infection, post ART, and following analytical treatment interruption. In aim 2, we will determine the effects of
translocated microbiome upon MAIT-neural cell interactions. Overall, the findings from this R21 proposal could
open new immunotherapy avenues for PLWH with neurological disorders despite virological suppression by ART
by targeting MAIT cells as one of the key immune mediators of the gut-brain axis.

Public health relevance
Project Narrative Persistent CNS immune activation is a hallmark of HIV neuropathogenesis, and persists even in people living with HIV (PLWH) who are on suppressive ART, with limited clinical success in treating HIV-associated neurocognitive disorders (HAND). The identification of intestinal dysbiosis in PLWH with HAND despite ART has highlighted the importance of gut–brain communication, and identification of the components responsible for this crosstalk provides a potential therapeutical lead. In this project, we hypothesize that mucosal-associated invariant T cells (MAIT cells), a cell type with antimicrobial activity involved in maintenance of homeostasis of the gut mucosal microbiome and detected in the cerebrospinal fluid (CSF) and brain tissue of PLWH, are a major immune cell type that mediate the crosstalk between gut dysbiosis, microbial translocation, immune cell dysfunction, and central nervous system co-morbidities in PLWH.